Particulate matter size, epithelial barrier dysfunction, and chronic rhinosinusitis

ABSTRACT
Goal: The proposal outlined in this career development award (CDA) will provide Dr. Amarbir S. Gill with the
protected time and training needed to develop into a successful, independent clinician-scientist. Dr. Gill's long-
term career goal is to develop a translational research program that employs advanced molecular laboratory
techniques to elucidate effects of environmental exposures on sinonasal epithelial barrier dysfunction in
chronic rhinosinusitis (CRS) and identify key management strategies. Training: To achieve his goal, Dr. Gill has
assembled a mentorship team that takes advantage of deep expertise in epithelial pathobiology, environmental
exposures, label-free imaging, and bioinformatics at the University of Michigan, and has a strong track-record
of mentoring K awardees to independence. Research: CRS is a debilitating inflammatory disease of the upper
airway that affects up to 12% of the U.S. population. People with CRS battle daily nasal congestion, smell loss,
nasal drainage, facial pain, as well as chronic fatigue, and sleep and cognitive dysfunction. The quality-of-life
(QOL) impairment associated with CRS is on par with that of coronary artery disease, Parkinson's disease,
and end stage renal disease. Despite its wide prevalence and significant morbidity, CRS remains an under-
researched disease with limited effective treatment options. Available therapies fail to help more than 250,000
patients annually who then undergo sinus surgery, underscoring a critical need for improved knowledge of
underlying molecular mechanisms driving disease pathophysiology. To this end, recent investigations have
demonstrated that particulate matter (PM) exposure can increase the risk of developing CRS, while also
impacting disease severity and surgical outcomes. We have shown these observations to be consistent for
small, but not large PM particles. The present proposal seeks to understand the differential epithelial
penetration and pathogenic potential of small vs. large PM particles, while identifying the role of sinonasal tight
junctions (TJs) in propagating PM-mediated dysfunction of the sinonasal epithelial barrier in CRS. Our central
hypothesis is that compared to large PM, smaller PM particles exhibit better sinonasal tissue penetration,
allowing them to enter epithelial cells and initiate epithelial barrier dysfunction by downregulating key TJs, such
as claudin proteins. To study this hypothesis, we will innovatively adapt fluorescence lifetime imaging
microscopy (FLIM) – a label-free imaging tool that leverages differences in the autofluorescence spectra of PM
and epithelial cells to track the movement of small and large PM particles – to in vitro air-liquid interface cell
cultures and sinus biospecimens from individuals with CRS with nasal polyps, the most severe form of CRS. In
doing so, we will define mechanisms facilitating size-dependent PM modulation of disease, uncover potential
therapeutic targets, and inform novel management strategies.

Public health relevance
PROJECT NARRATIVE Chronic rhinosinusitis (CRS) affects over 20 million individuals and costs our healthcare system $22B every year, yet it remains poorly understood with limited treatment options. Keeping in mind the increasing levels of forest fires in the U.S. – a major source of atmospheric particulate matter (PM) – the proposed research is relevant to public health as it will 1) elucidate a fundamental understanding of PM disease mechanisms; (2) identify key players driving disease pathophysiology for therapeutic targeting; and (3) accrue knowledge that will help inform air quality policies and standards. The proposed research will further the NIH's mission to acquire novel fundamental knowledge about living systems that can be used to enhance health and reduce illness and disability.